Development and Translation of Advanced Motion Correction Technologies for Cardiac PET/CT

Abstract
Motion effects (including respiratory motion, body motion, cardiac motion) and associated mismatched
attenuation correction substantially degrade the cardiac PET image quality and quantitative accuracy. Although
a number of motion correction methods have been implemented on clinical scanners, they 1) are largely
respiratory motion corrections requiring external motion tracking hardware; and 2) does not take into account
motion-induced PET-CT mismatch in attenuation correction. The correction of motion for 82Rb cardiac dynamic
PET imaging is particularly challenging, as the rapid tracer kinetics of 82Rb leads to substantial tracer distribution
change in the dynamic frame images over time. 82Rb’s ultra-short half-life of only 75 seconds also poses
additional significant challenges of image noise.
In this R01, we propose to develop a series of motion correction methods with aligned PET-CT for both static
and dynamic cardiac applications. All the new developments proposed here are data-driven based approaches,
meaning no external motion tracking hardware is required. We will focus on cardiac PET data with 82Rb as the
tracer, while most of the developments can be directly applied to other tracers. The proposed motion correction
technology developments and translations will have a significant impact on both currently used clinical protocols
and emerging new applications, such as evaluation of endocardial/epicardial (EN/EP) flow ratios. Specifically, in
Aim 1, we will develop and optimize respiratory and bulk body motion correction methods. In Aim 2, we will
develop and optimize data-driven methods to correct cardiac (intra-beat) motion. In Aim 3, we will develop
methods to correct PET/CT mis-alignment due to motion. All the developed technologies will be evaluated and
validated using human and large animal data. In Aim 4, the industry partner of this grant will translate the
developed motion correction methods to end-users.

Public health relevance
Narrative The proposed motion correction technology developments and translations will have a significant impact on both currently used clinical protocols and emerging new applications as in the evaluation of patients with Ischemia and No Obstructive Coronary Artery Disease (INOCA), heart failure with preserved ejection fraction (HFpEF) or aortic stenosis.